Improving Post-Acute Care to Reduce Ethnic Stroke Disparities

Abstract
Mexican Americans are the most numerous sub-group of Hispanic Americans, the largest minority population
in the United States. This important group is aging, growing rapidly and spreading throughout the country. For
the past 19 years the Brain Attack Surveillance in Corpus Christi (BASIC) Project has provided rich original
stroke disparities research comparing Mexican Americans and non Hispanic whites. BASIC has demonstrated
that stroke incidence is higher in Mexican Americans compared with non Hispanic whites and that the relative
Mexican American:Non-Hispanic white stroke disparity remains completely unabated over the last decade.
Further, Mexican American stroke survivors have worse neurologic, functional, cognitive and quality of life
outcomes compared with non Hispanic whites for reasons that are not yet understood. Worse stroke outcomes
in Mexican Americans are not explained by socio-demographics, including education and insurance, stroke
treatment, stroke severity or subtype, or pre-stroke factors. One potential explanation for the ethnic differences
in stroke outcome is differences in post-acute care (PAC) in the form of rehabilitation or insufficiently resourced
informal care. Virtually no data exists on stroke rehabilitation or informal stroke caregiving in Mexican
Americans to inform this hypothesis. The current proposal will leverage the infrastructure of the longstanding,
population-based BASIC Project to explore PAC in Mexican Americans and non-Hispanic whites from multiple
perspectives: patients, caregivers, and community. First, the study will collect detailed data on PAC in the 90
days following stroke and explore the predictors of PAC, including socio-economic and cultural factors, and
how these may differ by ethnicity. We will capitalize on the rich stroke outcome data collected in BASIC to
explore for the first time ethnic differences in PAC and their influence on ethnic disparities in stroke outcomes.
Second, the study will enroll stroke caregivers and collect comprehensive data on the caregiving experiences
and outcomes of individuals providing informal care to stroke survivors. Finally, the study will employ an
innovative strategy to determine gaps between the needs of informal caregivers and available community
resources for caregiving. This line of research will inform culturally sensitive intervention strategies across
multiple levels to improve stroke outcomes in Mexican Americans, a growing, aging and large minority
population that will increasingly feel the impact from stroke in the next decade. BASIC is the only study capable
of addressing these important questions about stroke in Mexican Americans.

Public health relevance
Project Narrative This project will leverage the infrastructure of the longstanding Brain Attack Surveillance in Corpus Christi (BASIC) Project to investigate multiple aspects of post-acute care following stroke in Mexican Americans and non-Hispanic whites including rehabilitation, informal caregiving, and gaps between caregiving needs and available community resources. Results from the study are critical initial steps to reduce Mexican American stroke outcome disparities.